CLINICAL LUNG CANCER RESEARCH PROJECT

The development of therapeutic modalities for the treatment of human lung cancer has, to date, been disappointing. Classification of lung tumors with regard to their metabolic potential is particularly important for developing a systematic approach for the identification of active antilung tumor agents. We have, therefore, initiated this project in order to develop a relevant and feasible plan for classification of human lung tumors, as well as for identification of effective new lung cancer treatment modalities. This project will interface the clinical aspects of human lung cancer with basic science and applied science technologies which are currently available in an effort to provide a comprehensive program for characterization of lung tumors based on their morphological, ultrastructural, biochemical, metabolic, and molecular genetic characteristics as well as establish in vitro and in vivo techniques for investigating potential antitumor drugs against primary human lung tumors. The initial results from our laboratories document the feasibility and relevance of this project by demonstrating: (1) considerable variation in prostanoid as well as 4-ipomeanol metabolism among individual fresh human lung tumor specimens, (2) the ability to establish and propagate primary lung tumor cell cultures which will provide material for in vitro drug screening, establishing long term tumor cell lines, and for comparative biochemical studies, (3) the ability to propagate human lung tumors in the lungs of nude mice by a novel intrabronchial implantation method which will allow for improved in vivo propagation and drug screening studies. An ultimate goal of this project is to provide a paradigm for individualized lung cancer characterization and treatment as an improvement over current approaches.